Brain-behavior vulnerability to sleep loss in children: a dimensional study of attention and impulsivity

Project Summary
Children and adolescents increasingly experience insufficient or poorly timed sleep as early school start times
collide with maturational changes in sleep regulation. However, we lack a deep understanding of both the
brain-behavior consequences of this sleep loss and the factors that distinguish which children may be
increasingly vulnerable and which are comparatively resilient to its effects. This is particularly salient for the
brain-behavior mechanisms underlying attention and impulsivity: two cognitive domains which are acutely
impacted by sleep loss, are critical for academic success, and are core aspects of neurodevelopmental
disorders such as attention-deficit/hyperactivity-disorder (ADHD). Attempts to address these issues are
hindered by limited mechanistic studies, overreliance on data from adults, and the use of neurotypical samples
only. Thus, this R01 project tackles these challenges with a within-subject at-home sleep restriction experiment
with combined methods of fMRI, neurocognitive testing, EEG, and circadian physiology to bear on this
important problem. We aim to enroll (over five years) 150, 10-13-year-old children across levels of inattention
and impulsivity. We will compare a sleep optimized baseline to 5 nights of sleep restriction. Each child is
characterized on several attention and impulsivity metrics to compile baseline risk scores for each domain.
Resting neural arousal (waking frontal EEG theta power) and circadian timing (melatonin onset phase angle)
index sleep-relevant physiology as candidate mechanisms altering a child’s resilience to sleep loss. Repeated
functional magnetic resonance imaging using task-based and resting paradigms, with complex modeling of
behavior variability characterizes sleep loss’s impact on attention and impulsivity. A performance battery
indexes neurocognitive impairments relevant for academic achievement. Finally, machine learning is used to
determine examine distinct phenotypes of baseline risk factors and sleep-loss vulnerability in our sample. In
sum, this project will advance both NICHD and NIMH’s goal to understand mechanisms of complex behavior;
here, consequences and mediators of sleep loss for children.

Public health relevance
Project Narrative Chronic insufficient sleep during the school week is an ever present concern for children and adolescents with consequences particularly for attention and impulsivity. We currently lack an ability to mechanistically detect which child will be most vulnerable to insuffient sleep. To address this need, we propose an at-home sleep restriction experiment mirroring a school week, with neuroimaging, performance testing, and assays of neural arousal and circadian timing to untangle factors altering children with severe attention and impulsivity experience the consequences of sleep loss.